Open Drug Discovery Center for Alzheimer's Disease

The Open Drug Discovery Center for AD (Open-AD) Structural Biology core aims to provide
Target Enabling Packages (TEPs): a combination of experimental tools and knowledge that will
allow researchers to investigate the biology of potential drug targets and to test therapeutic
hypotheses. The TEPs will consist of: gene knockout reagents and cell lines; purified target
proteins for functional studies and for the development of antibodies and inhibitors; and
structures of proteins and protein:ligand complexes, to understand protein functions and support
drug development. Target selection and the definition of the required experimental tools will be
determined in consultation with the Bioinformatics and the Admin and Data Cores, which will
bring in community expertise. The Structural Biology core will have a central role within the
Open-AD project, providing purified proteins for assay development and screening by the
Assay core and structural data to guide chemical development by the MedChem core. By
releasing all reagents and data, we will enable and promote deeper and wider study by the
biomedical research community. The Structural Biology core team is already engaged in active
collaboration with the Mangravite and Levey groups, generating TEPs for targets discovered in
the AMP-AD consortium; some of these TEPs will form the basis of the first chemical
development programs within the new proposed Open-AD project.

Public health relevance
The narrative is attached in overall section.